OCTREOTIDE (SANDOSTATIN) IN TREATMENT OF PATIENTS W/ ACTIVE CROHNS DISEASE

To determin if Sandostatin (octreotide) improves clinical status, endoscopic appearance and intestinal tissue histology in patients with Crohn's disease